AutoDock Suite: High Performance Software Environment for Drug Design

Project Summary
Computational docking is an essential tool for drug discovery and design, and it has been essential to the
development of many drugs currently in clinical use. Given the growing availability of experimentally
determined structures with atomic resolution, its application has become among the most important
structure-based methods. The key role played by docking is underscored by the number of publications about
it (more than 110k citations in the last 4 years), and its key role in the development of many drugs currently in
clinical use. Despite being used now routinely by many researchers for decades, there are still many open
challenges that need to be addressed. One of the main ones is the increase of accuracy of the scoring
function, which would lower the number of false positives from virtual screenings, and increase the success
rates. The other is the need for more efficient computing performance to be able to virtually screen not only the
very large virtual libraries that have been developed recently (which can now easily contain even billions of
chemicals), but also the new large macromolecular complexes that are being characterized with cryoEM, as
well as homology modeling and de novo modeling. The combination of these limitations hinders the
applicability of docking to these problems. We are proposing to develop better tools to address these
challenges, to improve speed, accuracy, and provide the capability of navigating through large libraries and
macromolecular structures.

Public health relevance
Project Narrative Computational docking is an essential tool for drug discovery and design, and it has been essential to the development of many drugs currently in clinical use. Nevertheless, there are many challenges that still need to be addressed, from the availability of better models to calculate predicted binding affinity, to methods to support virtually screen libraries containing billions of chemicals from which potential drug candidates could be identified. We are proposing to develop better tools to address these challenges, to improve speed, accuracy, and provide the capability of navigating through these large libraries.